Adult Relationship Sequelae of Child Abuse and Neglect: Multiple Developmental Cascades

ABSTRACT: PROJECT 2
Child abuse and neglect (CAN) is a robust risk factor for the development of significant social difficulties in
adulthood. However, the predominant use of retrospective measures of broad ill-defined CAN experiences in
broader cross-sectional designs that rely on single methods or informants has limited our understanding of the
associations among specific dimensions of CAN and characteristics of close relationship experiences in
adulthood. Moreover, from a public health perspective, the CAN experiences of historically underrepresented
individuals are also substantially underrepresented in the scientific literature in spite of the disproportionate
suffering they experience as victims of CAN in the broader context of discrimination, systematic structural
inequities, and substantial barriers to health care access. Finally, at a substantive level, studies have yet to
systematically delineate the mediating processes and moderating conditions that account for the multiple
developmental cascades linking CAN with close relationship sequelae in adulthood.
To address these substantial gaps in scientific knowledge, the present application is designed to provide
the first test of an integrative process model of the relational vestiges of CAN in adulthood. Specific aims are
centered on examining: (1) the selectivity and breadth of prospective associations among CAN dimensions and
multiple domains of intimate partner and parent-child relationship qualities; (2) the psychological mechanisms
that mediate the adult relational sequelae of CAN; and (3) the multi-level moderating conditions that potentiate
or disrupt the mediating cascades linking CAN with close relationship experiences in adulthood. Given the
relative lack of research on participants from diverse demographic backgrounds, the proposed application is
specifically designed to advance an understanding of the sequelae of CAN in an economically marginalized
sample of individuals who predominantly identify as Black or Latinx.
Building on the solid base of an integrative conceptual framework and promising preliminary findings, this
application will test these aims by following up a sample of 427 28- to 32-year-old adult participants who
experienced substantially elevated CAN and participated in data collection during early adolescence (Wave 1:
10-12 years old) and emerging adulthood (Wave 2: 18-20 years old). To overcome the existing methodological
limitations in the literature, we capitalize on a multi-method (e.g., observations, surveys, semi-structured
interviews, structured interviews, q-sorts), multi-informant (e.g., trained coders, counselors, primary caregivers,
friends, peers), and multi-level (i.e., ecological, family, interpersonal, intrapersonal, neurocognitive,
neurobiological) measurement battery across three prospective measurement occasions encompassing more
than two decades. By identifying the mechanisms and conditions underlying links between CAN and adult
relational sequelae, this application will provide critical information for clinical and policy initiatives designed to
maximize the welfare of children and families.